Ebola virus VP24_a novel inhibitor of interferon and oxidative stress signaling

DESCRIPTION (provided by applicant): Ebola viruses (EBOVs) are NIAID category A priority pathogens that cause severe viral hemorrhagic fever. A critical research task is to define how the molecular interactions between filoviruses and the human host trigger life-threatening infections. Defining such interactions will shed light on the triggers of viral hemorrhagic fever and will facilitate prophylactic and therapeutic interventions for this frequently lethal syndrome. We hypothesize that evasion of host innate defenses, particularly interferon (IFN)-α?β responses, is critical to the uncontrolled virus replication and inflammation characteristic of EBOV infections. We previously demonstrated that the EBOV VP35 protein inhibits production of IFNα?β and, consistent with a critical role for VP35 as a virulence factor, a VP35 mutant EBOV defective for suppression of IFNα?β responses was avirulent in guinea pigs. We also demonstrated that that the EBOV VP24 protein inhibits IFN-induced Jak-STAT signaling by preventing the trafficking of phosphorylated STAT1 to the nucleus. This project builds upon these and other observations regarding the function of VP35 and VP24 to define their mechanisms of action, their impact on EBOV replication and their impact on EBOV pathogenesis. Based on data demonstrating that interaction of VP24 with karyopherin alpha nuclear localization signal receptors inhibits phospho-STAT1 nuclear import, we will define the mechanism by which VP24 blocks STAT1 nuclear import and assess the impact of VP24 on the nucleo/cytoplasmic trafficking of other karyopherin alpha cargoes. We also observed that VP24 inhibits the induction of cellular antioxidant responses normally mediated by the transcription factor Nrf2. Because Nrf2- induced antioxidant responses have been increasingly implicated in responses, including innate immune responses, to virus infection; we will determine the mechanism by which EBOV VP24 inhibits the Nrf2-induced antioxidant responses and the consequences of this inhibition for innate immunity. As multiple mechanisms have been identified by which EBOV VP35 inhibits IFNα?β signaling, including sequestration of dsRNAs, interference with the kinases IKKε and TBK-1 and inhibition of interferon regulatory factor 7 function; we will dissect out the contribution of these functions to inhibition of IFNα?β production. Finally, mutant recombinant EBOVs will be generated to determine how VP24 and VP35 immune evasion functions contribute to viral replication and virulence. The results of these studies will shed light on the contribution of VP24 and VP35 to EBOV pathogenesis and identify viral functions that may be targeted for antiviral development. PUBLIC HEALTH RELEVANCE: Ebolaviruses (EBOVs) are emerging viruses that cause severe viral hemorrhagic fevers and are therefore considered a public health threat. Currently, the factors used by these viruses to cause severe illness are not well-defined. The experiments in this proposal will clarify the role of two viral proteins, VP24 and VP35, in EBOV disease and suggest new ways to prevent or treat these infections.

Public health relevance
Project Narrative Ebolaviruses (EBOVs) are emerging viruses that cause severe viral hemorrhagic fevers and are therefore considered a public health threat. Currently, the factors used by these viruses to cause severe illness are not well-defined. The experiments in this proposal will clarify the role of two viral proteins, VP24 and VP35, in EBOV disease and suggest new ways to prevent or treat these infections.